Care Disengagement Prevention in Treatment Naive Indonesian Living with HIV

Summary
Indonesia is facing a looming HIV crisis. In Asia, the population size of people living with HIV (PLH) in
Indonesia is second only to that in India and China. Currently, HIV epidemics disproportionally impact a
handful of key populations marginalized within its society. One of the most critical reasons for the increasing
mortality among people living with HIV (PLH) in Indonesia is their dismal engagement in HIV treatment.
According to recent estimates from UNAIDS, while there were an estimated 540,000 PLH in Indonesia in 2022,
only 179,659 (33.27%) were reportedly on antiretroviral therapy (ART), 36,821 (6.82%) were regularly tested
for viral load, and 33,395 (6.18%) achieved viral suppression. The majority of Indonesian PLHs are lost across
the HIV care continuum, even after the government's Strategic Use of Antiretroviral Therapy (SUFA) program
launched in 2013. The reasons for this failure to retain PLH in care include insufficient knowledge and limited
accessibility and affordability of care, but the most prominent barrier is fear of stigma. Stigma not only deters
PLH from seeking care but also strains patient-provider relationships. Indeed, stigma is considered the
greatest barrier to ending HIV in Indonesia. As the world’s largest Muslim-majority country, accounting for 13%
of the global Muslim population, Indonesia's cultural meanings surrounding HIV, especially with respect to
gender, sexuality, and substance use, are rooted in the local “religious-familial” complex. As such, there is an
urgent call for culturally adapted interventions to help curb HIV related stigma among PLH to promote their
treatment engagement. The purpose of this study is to culturally adapt an intervention to reduce stigma and
prevent treatment disengagement among Indonesian PLH, and evaluate its feasibility, acceptability, and
primary efficacy. The scientific premise is that HIV stigma remains rampant in Indonesia and has severe
negative impacts on treatment engagement among Indonesian PLH. This study addresses the critical need to
increase treatment engagement among Indonesian PLH and retain PLH in care by addressing the stigma
surrounding HIV. Study aims are: 1. Utilize the ADAPT-ITT model to culturally adapt an evidence-based stigma
reduction intervention using in-depth interviews with 30 Indonesian PLHs and two focus groups with
stakeholders (n=12) while gathering data on stigma experiences and HIV care engagement. 2. Test the
feasibility, acceptability, and preliminary efficacy of the adapted intervention for stigma reduction and care
engagement, through use of a stratified, waitlisted randomized-controlled design with 80 Indonesian PLHs with
a follow-up of 26 weeks. HIV related stigma can have profound negative impacts on PLH’s engagement across
the care continuum, especially in resource-limited settings with tenacious religious-familial cultural norms. This
study would be one of the first studies to promote treatment engagement by addressing HIV related stigma
linked to the local religious-familial complex in a Muslim-majority country.

Public health relevance
Project Narrative As of 2023, Indonesia ranks 20th worldwide in the number of people living with HIV (PLH), with close to 0.6 million of its population currently living with HIV and remains as one of Asia's fastest-growing HIV epidemics, second only to India and China. The majority of Indonesians living with HIV are lost to follow-up in HIV care. The purpose of this study is to culturally adapt a stigma-reduction intervention to prevent treatment disengagement among Indonesians living with HIV and evaluate its feasibility, acceptability, and primary efficacy.